Methamphetamine Activation of Inflammasome and Altered immunity in HIV (MAIA) Study

PROJECT SUMMARY/ ABSTRACT
Despite over four decades of research, we still do not have an HIV cure. While antiretroviral therapy (ART) is
able to suppress virus to undetectable levels, it is not a cure; virus rapidly rebounds from latently-infected cells
(“the HIV reservoir”) within weeks after ART interruption. Thus, a major goal is to eradicate the HIV reservoir in
order to achieve clinical remission. However, high-risk individuals, such as those who use methamphetamine
(MA), are most likely to benefit from HIV cure strategies and yet often have high rates of suboptimal ART
adherence and poorer clinical outcomes. Recent preliminary work from our group showed for the first time that
MA is associated with increased inflammation (e.g., via the NOD-like receptor family pyrin domain containing 3,
NRLP3, inflammasome activation pathway) and residual HIV transcription. The proposed work now aims to
identify how MA-induced inflammasome activation leads to immune dysfunction in PWH, even during ART
suppression. Leveraging rare existing longitudinal blood samples from PWH on ART with and without MA
(MA+/MA-) use from the UCSF EMRLHD (Effect of Methamphetamine on Residual Latent HIV Disease) study,
as well as prospectively collected blood and cerebrospinal fluid (CSF), we will test whether MA promotes immune
dysfunction in PWH on ART via a multi-step process: (1) alteration of metabolism, leading to (2) epigenetic
changes, which then promotes (3) enhanced inflammasome-mediated signaling and (4) antiviral interferon (IFN)
signaling, resulting in (5) altered immune dysfunction. Using advanced single cell methods (e.g., single cell
sequencing of RNA and chromatin accessibility, high-dimensional flow cytometry), methods which are
increasingly being used to prioritize targeted cell-based therapeutics, we will (a) directly test and validate that
MA exposure leads to inflammasome activation and inflammation (Aim 1), and then subsequently promotes
immune dysfunction in T cells (Aim 2) and B cells (Aim 3). In Aim 1 we will determine whether MA alters induces
inflammasome activation and inflammation secondary to MA-induced metabolic (e.g., metabolomics) and
epigenetic (e.g., scRNA/ATAC-seq) alterations, perform in vitro validation of our findings. In Aim 2, we will then
determine whether MA confers antigen-specific T cell dysfunction and HIV reservoir activation, performing in
vitro validation to determine the magnitude of MA-induced HIV gag-specific responses, cytokine production,
histone modification, immune dysfucntion (PD-1, TOX, IRF4), and viral reservoir reactivation (LARA assay). In
Aim 3, we will determine whether MA leads to MA-induced post-translational antibody modification (e.g.,
glycosylation, sialylation) and Fc dysfunction (e.g., ADCC, ADCP, ADNP), performing in vivo validation
comparing the magnitude of antibody neutralization from pre- and post-vaccination blood and CSF samples. The
proposed work will generate critical data informing how MA-induced activation of the inflammasome promotes
altered immunity in PWH on ART, and provide a framework by which to study additional therapeutic targets for
reducing inflammation and morbidity (and potentially, inducing HIV remission) in all PWH.

Public health relevance
PROJECT NARRATIVE The goal of HIV cure research is to eliminate persistent virus (“the HIV reservoir”) to overcome the need for lifelong antiretroviral therapy (ART) and improve clinical outcomes in people with HIV (PWH), but a challenge in achieving worldwide HIV eradication is targeting specific vulnerable populations who are most likely to benefit from an HIV cure and possess poorer immune responses due to chronic inflammation and ongoing HIV reservoir activation. Our preliminary data suggests that PWH with methamphetamine (MA) dependence disorder, even with adequate ART suppression, have elevated inflammation and HIV reservoir transcription. The proposed work will now leverage a unique longitudinal cohort of PWH on ART with and without MA use to determine the underlying mechanisms by which MA may lead to immune dysfunction, focusing on the NOD-like receptor family pyrin domain containing 3 (NRLP3) inflammasome activation pathway.